Biomedical Information Technology, Software Development, and Informatics Support

The purpose of this Statement of Work (SOW) is to acquire professional Biomedical Consultation and Information Technology, Software Development, and Informatics Support (BITSDIS) services for the National Cancer Institute (NCI) Center for Biomedical Informatics and Information Technology (CBIIT) including:

(1) NCIP HUB Maintenance Support Services in support of the NCI Community HUB Project, (2) Clinical Trial Reporting Program & Technical Support Services in support of Projects (a) Cancer Data Commons Framework, (b) CDISC and ePRO Support, (c) Clinical and Translational Research and Development and Support, (d) CTRP Program Support Analysts/Consultants, (e) IDS Operations and General Support, and (f) NCI Precision Medicine Analysis and Coordination Center, (3) Enterprise Vocabulary Support Services in support of the EVS Content Development, Maintenance, Operations Support Services Project, (4) Metadata Development, Curation, Harmonization & Program Support Services in support of the Metadata Curation and Harmonization Support Services Project, (5) Clinical Trials Reporting Program Support Services in support of the CTRP Clinical Trials Database Project, (6) Clinical Reporting & Research Informatics Support Services in support of Projects (a) CTRP Clinical Trials Database, (b) DCTP Patient Portal, (c) Instep, and (d) NCI Precision Medicine Analysis and Coordination Center, (7) Clinical Trials Reporting Office Support Services in support of the CTRO Data Abstraction Project, and (8) Cancer Research Data Commons Sustainability Implementation Support Services in support of the NCI Cancer Research Data Commons Project.